Cytoplasmic mechanisms of gene regulation: intersections and coordination

SUMMARY
Different regulatory pathways work together to coordinate gene expression, and our guiding philosophy
has been that exploring the interface of different types of regulation is thus a good way to discover new
and important biology. Building on discoveries from our previous MIRA award, we propose to focus on
understanding how different strategies for post-transcriptional regulation—mRNA decay, translation, and
protein decay—act together to control gene expression.
In the ﬁrst of our two themes, we will explore the idea that protein decay acts as a meta-regulator
of the post-transcriptional landscape of the early embryo. Using Drosophila melanogaster as a model
system, we will investigate one of the earliest steps of development, the maternal-to-zygotic transition.
During this process, maternal gene products are replaced with zygotic ones, and we have discovered
that removal of three maternal RNA binding proteins is critical and determined how their destruction is
developmentally controlled. We propose to extend this line of investigation to other RNA binding proteins
that are destroyed by distinct and unknown mechanisms in the early embryo. We want to answer three
critical questions: what are the mechanisms by which these other RNA binding proteins are destroyed?
How is their degradation developmentally controlled? How does their degradation in turn change post-
transcription regulation? Our research is signiﬁcant because our results will reveal how destruction of
maternal proteins shapes the regulatory landscape of the early embryo, and they will likely provide a
conceptual framework applicable to other types of developmental transitions.
In the second theme, we will explore how the open reading regulates mRNA decay and
translation. Poor (or “nonoptimal”) codons lead to reduced protein output, and understanding the
underlying mechanisms remains an open area of research for the ﬁeld. We have excitingly found that
nonoptimal codon usage represses translation initiation in human cells. This pathway is at least as potent
as previously described pathways like mRNA decay. Our proposed program will build upon these results
at a mechanistic level and will answer the following three important questions: What is the role of the
poly(A) in translational repression due to nonoptimal codons? What factors mediate translational
repression? How does codon-mediated regulation change during early development? This last question
represents a new direction for our lab and leverages our unique combination of skills in the Drosophila
MZT and codon-mediated regulation. Our research will reveal the molecular basis for a major repressive
pathway mediated by nonoptimal codons. The systems we establish have the potential to reveal other
types of developmentally-coordinated translational control, and we anticipate that our research will
provide a launching point to explore the how gene regulation changes in biological space and time.

Public health relevance
NARRATIVE Although all cells have the same collection of genes, what makes them different is which genes are turned on and which are turned off. When genes are inappropriately expressed, cancer can sometimes occur, or the development of an organism can occur improperly. This proposal focuses on understanding links between different steps in turning on a gene, in particular, the relationship between destroying the ﬁnal protein product, making the protein product, and getting rid of intermediate products.